The influence of food insecurity on reward neurobiology in children

Project Summary
Food insecurity (FI) – i.e., the “lack of consistent access to enough food for an active and healthy life” - is a
relatively common type of adversity in the United States and one which disproportionately impacts families in
rural counties (e.g., ~17% of rural families experience FI, compared to ~10% of all US families). FI is
associated with an increased risk for substance use (SU) in adults and adolescence and SU risk is also
generally greater for adolescents in rural areas, compared to their urban and suburban peers. While a causal
link between FI and SUD liability has not been established, prior work supports the postulation that the
experience of FI might increase the risk for SU via an impact on the neural substrates of reward processing.
For example, of the key components of FI (i.e., acute and repeated food deprivation and associated hunger,
stress, and poor nutrition), stress and poor nutrition have been shown to influence SU-relevant
neurodevelopmental trajectories, while food deprivation in children impacts neural processing for food rewards.
Furthermore, in adult humans and animal models, food deprivation increases reward sensitivity and risky
decision-making for primary and secondary rewards and increases drug-seeking and craving via functional
alterations in reward network areas in the brain (i.e., mesocorticolimbic regions). To more fully understand how
food deprivation in the context of FI might influence reward processes, this developmental study will examine
whether states of acute food deprivation that are sufficient to cause subjective feelings of hunger enhance
sensitivity for food and non-food rewards and increase risky decision-making (Aim 1). Moreover, we will
consider how associations between food deprivation and the neural substrates of reward processing are
impacted by FI (Aim 2) and whether FI mediates the associations between related factors (e.g., SES) and
reward processes (Aim 3) To address these aims, children (8-10 years old) from food secure (N=30) and
insecure (N=30) households in rural PA will undergo a counter-balanced, repeated measures fMRI paradigm,
once while food deprived (i.e., fasted) and once after a meal sufficient to satiate them (i.e., fed). We will focus
on children in order to minimize the impact of aspects of adolescence that might also influence these
processes and confound our results (e.g., SU, puberty). During fMRI participants will complete 2 versions of a
reward task in which they will make reward-related decisions (i.e., placing a bet of varying magnitude) for food
(i.e., candy) and non-food (i.e., money) rewards Data analyses will model the impacts of food deprivation
(fasted/fed; Aim 1) and food security status (secure/insecure; Aim 2) on reward neurobiology. Mediation
analysis will consider the relative contributions of FI vs. SES (Aim 3) and exploratory analysis will consider
potential moderators of FI-related effects (i.e., stress, nutrition, chronicity of FI; Aim 4). By considering whether
food deprivation in the context of FI drives functional alterations in reward processes, this exploratory R21
study will constitute a critical first step in identifying pathways by which FI drives SU-liability.

Public health relevance
Narrative Food insecurity and substance use are both common for youth in rural communities and evidence that food insecurity influences function in reward pathway regions in the brain that are also functionally impacted in substance use disorders suggests that they may be causally linked. Yet, potential mechanisms underlying an association between food security and substance use have not been considered in those who may be at greatest risk, i.e., children from rural families. This developmental R21 study will seek to: (1) determine the impact of food deprivation, a key component of food insecurity, on the neural substrates of reward processing in food insecure vs. secure children (8-10 years old); and, in doing so, (2) lay the foundation for a series of longitudinal studies that will delineate mechanisms by which food insecurity might serve as a risk factor for substance use.